THE EXTENDED VISUAL SYSTEM OF THE MACAQUE MONKEY

Although the project began with its focus on mapping the visually responsive cortical areas, the experiments also permit an analysis of the sensory-motor system. Normal control monkeys with their visual pathways intact responded to the visual cues by pressing a lever with one hand. This involved an asymmetrical pattern of local glucose utilization in brain involving a wide expanse of cortical and sub-cortical structures. An analysis of the pattern of asymmetry provides new information with respect to the localization sensory-motor function. The data obtained to date indicate that a much larger portion of brain regions are unilaterally activated on unimanual activity than has been appreciated previously.